Cellular and Molecular Physiology Core

PROJECT SUMMARY – CELLULAR MOLECULAR PHYSIOLOGY CORE
The Cellular and Molecular Physiology Core is the “work horse” of this Center, but it also continues to serve as
an innovation hub to provide liver investigators with the most up-to-date experimental models. The core is
organized to provide technical expertise, equipment and personnel to Liver Center Investigators in order to
provide them with state of the art cell and molecular research resources in an efficient, quality-controlled and
cost-effective manner. The Core has a long history of developing new cell and animal models for liver research.
Currently, the Core is divided into two Components: (1) The Cell Isolation and Cell Culture Component and (2)
The Molecular Component. These are subdivided into: (a) Isolated cell preparations, including: hepatocytes,
cholangiocytes, endothelial cells, stellate cells, portal fibroblasts and hepatic lymphocytes, primarily from mice
and rats. Human hepatocytes are also utilized when available. Over 3,400 separate cell isolations were
performed during the current award period; (b) Cell culture facilities for short and long-term cultures and cell
lines; (c) Protein and gene expression using Quantitative RT-PCR and Infrared imaging detection; (d) Altering
gene expression in liver-related cells, cell lines and tissues using siRNA transfection, adenovirus infection, and
CRISPR technologies; (e) providing a variety of animal models of liver disease and (f) disease-specific mouse
and human liver organoids, derived from iPSC’s, bile, and primary liver tissue. By centralizing these procedures
in a Core facility, cost and effort are dramatically reduced, investigators are assured of a high degree of rigor,
reproducibility, and quality control, and preparations can often be used simultaneously by more than one
investigator. Mario Strazzabosco, MD, PhD, who has more than 25 years of relevant experience, directs this
core with the collaboration of the Emeritus Director, James L. Boyer, MD, who has more than 4 decades of
experience working with these preparations and procedures. They are assisted by Romina Fiorotto, PhD, and
Shi-Ying Cai, PhD, which assures daily supervision, availability, and advice to investigators for many of these
services.